Rapid Assessment of Illicit Drugs in Wastewater

PROJECT SUMMARY/ABSTRACT
Opioid crisis (abuse and misuse) is an epidemic of global concern to public health and safety, causing over
70,000 deaths annually in the United States. Obtaining real-time data on the use of opioids is a major
challenge as this information is limited to population surveys and drug surveillance data. There is an urgent
public health need for monitoring tools to achieve crucial insight into the prevalence of opioid misuse/abuse
without stigmatizing communities. Wastewater monitoring is a proven strategy to identify areas needing
intervention instead of relying on emergency-room statistics and overdose deaths. However, current
wastewater drug analysis requires costly laboratory-based tests that involves labor intensive sample collection,
transportation, and analysis, resulting in long (days) turnaround times. Giner proposes to develop a compact,
portable, label-free Graphene Field Effect Transistor (G-FET) sensor utilizing high-specificity aptamers for
rapid, accurate, cost-effective, and multiplexing monitoring of opioid drug metabolites in wastewater samples.
Since it generates rapid results compared to incumbent methods which rely on batch sampling of wastewater
streams followed by expensive, time consuming analysis, this technology will provide actionable real time data
at a fraction of the cost of incumbent methods, encouraging broad use.
The goal of Phase II program is to demonstrate a field-ready prototype and a test methodology for
simultaneous detection of multiple opioid metabolites in wastewater at pg/mL levels. During the Phase I work,
Giner successfully detected three opioid metabolites in wastewater samples that are also associated with
street heroin use: Norfentanyl (a metabolite of fentanyl, a synthetic opioid), EDDP (a metabolite of methadone,
fully synthetic opioid), and Noroxycodone (a semisynthetic opioid, metabolite of oxycodone). We will also add
Morphine (main heroine metabolite, a natural opioid) to our Phase II program. Multiple samples from
wastewater treatment plants will be analyzed with Giner’s sensor and results will be cross-validated using the
gold standard HPLC-MS/MS method. Giner will achieve this by using its prior expertise in bio/sensors and
wastewater testing and in close collaboration with an interdisciplinary team of scientists, engineers, and
environmental wastewater epidemiologists. Once developed, the technology will also be suitable for detection
of any target illicit drug for which an aptamer can be prepared.

Public health relevance
PROJECT NARRATIVE Giner proposes to develop a compact, portable sensor instrument for rapid, accurate, and low-cost monitoring of opioid metabolites in wastewater. Given the growing opioid epidemic, and fatalities associated with synthetics such as fentanyl, the proposed wastewater monitor technology has broad potential to provide crucial information to address the public health and safety issues surrounding drug misuse and abuse. Fully developed, this technology will provide actionable real-time data at a fraction of the cost of incumbent methods and could find use at innumerable wastewater collection sites within large metro districts.